Microglial regulation of intermittent hypoxia induced phrenic motor plasticity

ABSTRACT
A well-studied model of respiratory motor plasticity is phrenic long-term facilitation (pLTF), a prolonged increase
in phrenic motor output following moderate acute intermittent hypoxia (mAIH). Over 2 decades, we developed a
nuanced understanding of intra-cellular mechanisms giving rise to pLTF, and factors regulating its expression in
the rest/light phase. With mAIH, serotonin-driven pLTF is constrained by modest adenosine 2A (A2A) receptor
activation. When extracellular adenosine levels are high, greater A2A receptor activation initiates an alternate
adenosine-dependent mechanism of plasticity. Although the serotonin driving plasticity arises from raphe
serotonergic neurons, the cellular source of adenosine was unknown. Thus, in the first 4 years of this grant, we
asked the question: what is the source of hypoxia-evoked adenosine? We developed an inter-cellular model
whereby phrenic motor neuron to microglia signaling evokes spinal adenosine formation and regulates pLTF.
During hypoxia, phrenic motor neurons release Fractalkine (Fkn) and activate receptors on the lone CNS cell-
type expressing Fkn receptors—microglia. Microglia respond by converting extracellular ATP to adenosine,
restraining serotonin-driven pLTF. These experiments were performed during the daily rest/light phase; our
discovery that mAIH delivered in the active (vs rest) phase profoundly impacts the mechanism driving pLTF due
to diurnal shifts in basal adenosine levels lead us to realize we must update our model to account for rest/active
phase differences. Two fundamental hypotheses guide this proposal: 1) shifts in microglial state across
the rest/active cycle alter phrenic motor neuron/microglia interactions and, thus, mAIH-induced pLTF;
and 2) microglial (and pLTF) responses to pro-inflammatory stimuli reverse in the active/dark phase.
Using a multi-disciplinary approach, we will interrogate a revised inter-cellular model by testing 5 hypotheses: 1)
Phrenic motor neuron-microglia fractalkine signaling inhibits pLTF less in the active/dark phase; even though 2)
Fkn receptor activation evokes greater active phase spinal adenosine formation; 3) Microglial expression of key
molecules for adenosine formation increases in the active (dark) phase; 4) Unlike the rest/light phase, mild
systemic inflammation has minimal impact, or even enhances active phase pLTF; and 5) Due to differences in
microglial reactivity, ventilatory LTF exhibits sexual dimorphism during the rest (not active) phase. We know little
concerning the impact of “biological clocks” in any aspect of ventilatory control, let alone respiratory plasticity.
Thus, we will expand on our discovery that time-of-day has powerful effects on AIH-induced pLTF by considering
the complex rest/active phase effects on phrenic motor neuron/microglia interactions. Regardless of outcome,
these studies will greatly advance our understanding of diurnal rhythms in respiratory plasticity and accelerate
ongoing efforts to develop AIH as a therapeutic modality to treat devastating human clinical disorders that
compromise breathing, threatening life itself. Greater understanding of diurnal rhythms is sorely needed since
nocturnal rodents and diurnal humans are typically studied in opposite phases of the rest/active cycle.

Public health relevance
PROJECT NARRATIVE A prominent model of plasticity in the neural system controlling breathing is phrenic long-term facilitation following acute intermittent hypoxia (AIH). After years of study in rodent models, AIH emerged as a promising treatment to restore breathing ability in devastating clinical disorders such as cervical spinal cord injury and ALS. Since humans and rodents have opposite diurnal rhythms, we seek funding in this application for competitive renewal to explore the critical role of diurnal rhythms in reciprocal phrenic motor neuron-microglia interactions demonstrated to regulate AIH-induced phrenic motor plasticity in the previous funding period.